Developmental Core

Project Summary/Abstract (Developmental Core)
The Developmental Core supports the goals of the Miami CFAR through the following aims:
1. Maintain a program for solicitation, peer review and oversight of pilot grants that promotes the research of
basic, clinical, and junior researchers to facilitate their path to successful extramural grants. Support will be
targeted to: a) junior investigators; b) investigators new to HIV/AIDS research; c) translational research that
fosters collaboration between basic and clinical researchers, including emerging opportunities; and d)
research activities of newly recruited UM faculty working in HIV.
2. Maintain a vibrant and intensive mentoring program, the Mentoring Academy, that guides junior faculty,
fellows and senior postdocs, and minority investigators, to successful independent careers.
The Developmental Core provides pilot funding and mentoring for investigators in order to obtain data to make
them more competitive for future independent funding in the field of HIV/AIDS from the NIH. The
Core encourages collaborations within the University of Miami and the other institutions in Florida. As the only
CFAR in Florida, Miami is able to offer funding in research opportunities to early-stage investigators (ESI) at
Florida institutions (Florida International University, University of Florida, Scripps) with a UM mentor. The
Mentoring Academy provides the CFAR with a program that trains mentors and mentees, guides ESI
in grant writing in an effort to outline a path to independent funding, and career development. The
Mentoring Academy will focus on developing the next generation of leaders for the CFAR. Funded ESI
have been appointed as Associate Directors to further establish their positions at the UM and in the
CFAR. The Ending the HIV Epidemic (EHE) supplements have formalized relationships between the
Developmental Core, community partners, and the Florida Department of Health (FDOH). The Core
leadership, Director Gwen Scott, MD, and Co-Director, Mario Stevenson, PhD, have excellent credentials in
NIH funding and reputation as quality directors at the UM Miller School of Medicine (MSOM). The Core’s
Co-Director of the Mentoring Academy, Adam Carrico, PhD, and Co-Leaders, Maria Alcaide, MD, and
Enrique Mesri, PhD bring experience in behavioral, clinical, basic and translational research. The Core will
continue to encourage researchers from underrepresented groups and high-risk populations in the
community in an effort to address and eliminate the health disparities that exist in South Florida. The
Developmental Core engages with the Administrative, Clinical Sciences, Laboratory Sciences, Bio-
Behavioral and Community Engagement Cores and the HIV and Aging Scientific Working Group in support
of the overall CFAR mission to provide awards that result in collaborations, publications, and successful
major grants in HIV/AIDS to end the HIV epidemic.